Dynamic regulatory mechanisms of robust pattern formation in the neural tube

Abstract
The long-term goal of our research is to understand the principles that permit developmental systems to
robustly construct embryos of the correct pattern, shape, and size. Developmental systems face a gamut of
variations from different sources including environmental, genetic, and stochastic, which manifest at multiple
levels from molecules to cells to organs. In the face of these challenges, organisms have been designed
through evolution to buffer the phenotype against these variations in order to robustly achieve a developmental
norm, a process Waddington termed canalization. As our knowledge of the molecular and cellular details of
patterning systems has expanded, there is now the opportunity to understand the systems level mechanisms
that give rise to robust pattern formation. Here we focus on pattern robustness through the lens of scaling and
size control. Scaling is a remarkable process in which the size of a pattern can be adjusted to the available
size of the tissue. Scaling has fascinated and baffled embryologists since the time of Hans Driesch who in
1885 found that when the blastomeres of a two-cell stage sea urchin embryo are separated, the result is not
two partial embryos but rather two complete embryos in which all their pattern is scaled by half. Similar results
have since been found in a variety of organisms, but the surgical manipulations required to generate size-
reduced animals are generally difficult and result in a lot of variability, thus limiting quantitative investigation.
Recently, we have developed a new method for generating zebrafish eggs of different size that is robust and
reproducible. Such embryos have qualitatively normal but scaled patterning and can give rise to viable adults.
At a molecular level we find that most gene expression patterns (e.g. morphogens and their targets) scale with
the tissues they pattern; however, a small subset of genes, the ones that sense tissue size to regulate scaling
(e.g. by interacting with morphogens), do not. Thus, these size altered embryos represent a powerful and
unique method to identify and determine the mechanisms of pattern scaling. Ultimately, tissue size is
determined by balancing the rates of proliferation and differentiation over the course of development. We have
found that the balance of proliferation and differentiation in the neural tube is under negative feedback control
by mechanical pressure/tissue packing. Here we will use a combination of quantitative imaging, molecular and
mechanical perturbations, and computer modeling to determine the systems-level mechanisms that allow: 1)
morphogen patterning to scale to fit the available space, and 2) proliferation and differentiation rates to be
balanced to cause a tissue to grow to fit the available space. These questions will be addressed in the
zebrafish neural tube, but we expect the resulting mechanisms to be widely applicable. Such an integrated
understanding is important for diagnosing and treating birth defects such as neural tube defects and in the
rational design of engineered tissues.

Public health relevance
Narrative Embryos use multiple interacting strategies to produce tissues that are patterned with remarkable precision despite numerous sources of variation. Here we look at two strategies that let embryos “fill the available space”: morphogen scaling and mechanical feedback on growth. Understanding these strategies will allow us to better prevent and treat birth defects and to engineer tissues for biomedical applications.